American Society of Biomechanics Annual Meeting

PROJECT SUMMARY The American Society of Biomechanics (ASB) is the foremost society for biomechanics research and engagement in the United States. The Society’s annual meeting brings together an interdisciplinary group of researchers interested in the application of mechanical principles to biological problems, both basic and applied. The research portfolio of ASB’s membership is highly interdisciplinary and complements the missions of the National Institute of Child Health and Human Development (NICHD) Center for Medical Rehabilitation Research (NCMRR) and National Institute Arthritis and Musculoskeletal and Skin diseases (NIAMS) by fostering discovery and dissemination of scientific knowledge through basic, translational, and clinical research that aims to enhance the health, productivity, independence, and quality of life of people with physical disabilities or musculoskeletal diseases. The 2020 annual meeting of the ASB, which will be held in Atlanta, GA, is being hosted by faculty at the Georgia Institute of Technology. The meeting will feature a variety of activities designed to foster a lively interchange of ideas, including podium presentations, thematic poster sessions, invited symposia, keynote lectures, poster presentations, topical tutorials, laboratory tours and a variety of mentoring, diversity and community outreach events. Student participation and mentoring are priorities for the Society. Meeting attendance is anticipated to exceed 1,000 delegates, of which, nearly half are expected to be students. Mechanisms have been established to specifically encourage and support the participation of women, underrepresented minorities, and persons with disabilities. Along these lines, under the direction of the current Diversity Chair, Robin Queen, PhD, the Society will continue to administer a Diversity Travel Award program, and organize four key events designed to (i.) engage underrepresented youth in the metro-Atlanta area on the topic of biomechanics of Olympic sports (Community Outreach); (ii.) provide mentorship on professional development strategies to mid-career scientists in the Society (Mentoring Lunch) (iii.) convene the women in the Society and offer strategies for negotiation across all career stages (Women in Science) and (iv.) bring together members of the Society to discuss systematic bias in the academy with a focus on gender and gender identity (Diversity and Inclusion Lunch). This grant application seeks funding to continue supporting Diversity Travel Awards for ~20 attendees of the meeting as well as support for the Olympic-themed Community Outreach event. Travel awards have now been offered at each of the last five meetings (2015-19) of the ASB to individuals with disabilities and from underrepresented backgrounds. These awards have proven to be successful in increasing diversity amongst young active members who over time will become the future leaders of the Society and the field.

Public health relevance
PROJECT NARRATIVE The 44th annual meeting of the American Society of Biomechanics (ASB) will be hosted by faculty of the Georgia Institute of Technology at the Atlanta Convention Center in Atlanta, Georgia, from August 4-7, 2020. This proposal seeks funding to continue Diversity Travel Award and Community Outreach programs targeted to increase the attendance of students, trainees, and junior faculty from underrepresented groups with a focus on engaging women, minorities, and persons with disability. These programs will provide opportunities for networking and the exchange of ideas around research themes intended to enhance the health, productivity, independence, and quality of life of people with physical disabilities and musculoskeletal disease – encapsulating the missions of both NICHD-NCMRR and NIAMS.